Coordinating Unit for the National Centers for Metabolic Phenotyping in Live Models of Obesity and Diabetes (MPMOD)

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The Mouse Metabolic Phenotyping Centers Live (MMPC-Live) will be a multi-center initiative funded by the NIH to provide state-of-the-art technologies to investigators for a fee, with their services including characterization of mouse metabolism, blood composition (including hormones), energy balance, eating and exercise, organ function and morphology, and physiology. The MMPC-Live Coordinating Unit (CU) will be responsible for supporting MMPC-Live by creating/maintaining the website and administratively organize the meetings and workshops sponsored by the MMPC-Live to engage the greater mouse metabolism scientific community. In addition, the CU will be responsible for managing and organizing the activities of the MMPC-Live Phenotyping Center sites to provide quality phenotyping services to the scientific community. The CU is responsible for creating and maintaining the administrative, scientific and informatics infrastructure necessary to organize and facilitate their operations. The goal of this proposal is to provide that infrastructure. Over the last 15 years, our group has successfully managed and created the infrastructure as the CU for the pervious NIDDK Mouse Metabolic Phenotyping Centers (MMPC). The mission of the MMPC was similar to MMPC-Live, allowing us to build upon the success of the established MMPC CU infrastructure to provide MMPC-Live with a robust and comprehensive service oriented solution that has been tested over time and supports the unique aspects of this consortium.

Public health relevance
The National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) is providing funds to establish the coordinating unit (CU) for the National Mouse Metabolic Phenotyping Centers Live (MMPC-Live) program. The CU will coordinate the interactions of the MMPC-Live Phenotyping Centers, interact with the Executive Steering Committee as well as provide a national web portal for MMPC-Live in order to disseminate information and provide an organizational infrastructure for the program. This application will provide the infrastructure for the CU for MMPC-Live.